COCOA PAD II: Effect of Cocoa Flavanols on the Gut Microbiome and Functional Performance

ABSTRACT
Lower extremity peripheral artery disease (PAD) affects more than 230 million people worldwide and is a major
cause of disability. Yet few medical therapies exist for PAD. Cocoa flavanols, from the seeds of theobroma
cacao, the “cocoa” tree, have therapeutic properties that may improve calf muscle perfusion and reverse the
gastrocnemius muscle abnormalities that contribute to disability in PAD. Our recently funded COCOA PAD II
Trial (R01-AG068458) is a multi-center double-blinded randomized trial that will test the effects of cocoa
flavanols vs. placebo on change in six-minute walk distance at six month follow-up in people with PAD.
Secondary outcomes include gastrocnemius perfusion, physical activity, brachial artery flow-mediated dilation
and gastrocnemius muscle biopsy measures of mitochondrial activity and skeletal muscle health. Preliminary
evidence supports our hypothesis that gut microbiota may be key mediators of the beneficial effects of cocoa
flavanols. First, gut microbiota metabolize cocoa flavanols including epicatechin (the main cocoa flavanol) to
produce metabolites that enter the circulation and reach target organs. The metabolites exert many beneficial
effects. Microbe-derived flavanol metabolites increase phosphorylation of endothelial nitric oxide synthase and
nitric oxide production. Second, dietary supplementation of cocoa flavanols may promote gut microbial taxa
associated with health. Therefore, we now propose an ancillary study to the COCOA PAD II Trial that will
enable us to collect and analyze stool and plasma samples collected at baseline and six month follow-up from
100 participants with PAD who will be enrolled in the COCOA PAD II Trial. We will test the following specific
aims: First, among people with PAD, we will determine whether baseline gut microbial diversity and
composition are associated with the degree of response to cocoa flavanols, measured by greater improvement
in six-minute walk distance and gastrocnemius perfusion at 6-month follow-up. Second, we will determine
whether cocoa flavanols, compared to placebo, favorably alter gut microbial diversity and composition at six-
month follow-up. Third, we will determine whether cocoa flavanol-induced changes in gut microbial
composition, compared to placebo, between baseline and 6-month follow-up are associated with greater
improvement in six-minute walk distance and gastrocnemius perfusion. Finally, we will perform microbe-
associated metabolomic profiling of blood samples at six-month follow-up to identify metabolomic profiles that
are associated with improved six-minute walk distance and gastrocnemius muscle perfusion at 6-month follow-
up. If our hypotheses are correct, this trial will, for the first time, establish the gut microbiome as a
critical mediator of improved walking performance in people with PAD. Results will also delineate a
key biologic pathway of improved walking performance in PAD, thereby identifying the gut microbiome
a therapeutic target for future interventions in PAD.

Public health relevance
NARRATIVE Older people with lower extremity peripheral artery disease (PAD) have greater walking impairment and faster functional decline than those without PAD. The COCOA PAD II randomized clinical trial will determine whether cocoa flavanols significantly improve walking impairment and/or prevent functional decline in older people with PAD, compared to placebo. The objective of this ancillary study is to collect stool and blood samples from participants in COCOA PAD II for studies of the gut microbiome and metabolites from gut microbiota in order to determine their role in regulating the effects of cocoa flavanols on walking performance.